Host factors influencing early clearance of Streptococcus pneumoniae from the middle ear following invasion from the nasopharynx

Project Summary
This proposal addresses the clinically significant issue of bacterial otitis media (OM), a major source of hospital
visits and preventable hearing loss in young children and the most common diagnosis for antibiotic
prescriptions in this age group. Streptococcus pneumoniae is one of the two most common causes of bacterial
OM, which results from bacterial invasion from the nasopharynx to the middle ear. Despite widespread vaccine
use, S. pneumoniae remains a significant OM pathogen, indicating the need for new therapeutic approaches.
However, large knowledge gaps remain regarding the host factors which contribute to bacterial OM
pathogenesis. To address these knowledge gaps, we developed a new mouse model of S. pneumoniae
invasion to the middle ear. This model is based on the clinical observation that viral co-infection increases OM
risk in children, and in mice promotes S. pneumoniae invasion. We find that serial administration of the viral
dsRNA analog poly(I:C) is sufficient to promote S. pneumoniae invasion to the middle ear. Poly(I:C) induces
the production of type I interferons (IFNs), which contribute to S. pneumoniae survival in other tissues. In the
first Aim, we address the hypothesis that type I IFNs enhance S. pneumoniae survival in the middle ear. Type I
IFNs can induce production of the anti-inflammatory cytokine IL-10, which we recently demonstrated
suppresses protection against S. pneumoniae infection in the lung. Here, we investigate whether IL-10
signaling in poly(I:C) treated mice enhances S. pneumoniae survival following middle ear invasion, as well as
the impact of IL-10 on middle ear inflammation. Together, these experiments will determine whether type I
IFNs contribute to S. pneumoniae OM pathogenesis. In the second Aim, we investigate the importance of the
host microbiome. Children treated with antibiotics are susceptible to recurrent bacterial OM, and pathogens
including S. pneumoniae are more resistant to antibiotics than many commensal (non-pathogenic) species. In
preliminary data, we find that antibiotic treated mice have increased S. pneumoniae invasion and reduced
neutrophil recruitment to the middle ear. We investigate the importance of microbiome-dependent neutrophil
recruitment for early clearance of S. pneumoniae following middle ear invasion. In the upper airway, the
prevalent commensal Corynebacterium has been identified by next-generation sequencing as negatively
correlated with OM in children, indicating a potentially protective role. Here, we determine whether
Corynebacterium improves protection against S. pneumoniae OM in our mouse model as a first step toward
developing new probiotic-based approaches for OM in children. The long-term goal of these studies is to
develop novel immunotherapy and/or probiotic strategies to improve the burden of OM disease.

Public health relevance
Project Narrative This proposal addresses the significant clinical issue of bacterial otitis media (OM). We developed a new mouse model to investigate how specific host innate immune responses and the microbiome impact clearance of the major OM pathogen Streptococcus pneumoniae following invasion of the middle ear. The goal of these studies is to identify critical factors which promote S. pneumoniae clearance from the middle ear in order to inform the development of novel immunotherapy and probiotic-based approaches for the treatment of bacterial OM.